Thyroid hormone signaling in skeletal muscle regeneration

Skeletal muscle has a high capability to regenerate after injury mostly because of the presence of muscle stem
cells (MuSCs). In certain situations, such as severe injuries (accidents, combat, and surgical injuries) or
degenerative diseases (muscle dystrophies), skeletal muscle loss cannot be repaired. This could be an even
more burden for the VA healthcare because combat Veterans have a higher risk of deployment-related muscle
injuries and long-term disabilities. Thyroid hormones act as pleiotropic factors in various tissues during
development by regulating genes involved in growth and differentiation, including skeletal muscle. Thyroid
hormones and thyroid hormone receptor α (THRA) play a crucial role in MuSCs proliferation and differentiation
and skeletal muscle regeneration after injury. This proposal will test the role of thyroid hormone signaling on
MuSC function during skeletal muscle regeneration in response to injury.
We are planning several studies devoted to extending our knowledge on the molecular basis of thyroid hormone
signaling in skeletal muscle regeneration after injury. We will further explore the collaborative interaction between
THRA and COUP-TFII and their role in skeletal muscle regeneration with in vitro and in vivo models. We plan to
use new in vitro system and in vivo mouse models that will allow studies on muscle regeneration. Our goal is to
identify therapeutic targets with the potential to promote MuSC proliferation and differentiation in response to
injury that can be useful for skeletal muscle repair and myopathies.

Public health relevance
Skeletal muscle injuries, including combat injuries and degenerative muscle diseases, lead to muscle loss. Skeletal muscle stem cells are the major players in skeletal muscle regeneration and maintenance. Understanding muscle stem cell behavior during muscle regeneration may result in the discovery of therapeutic targets for muscle loss secondary to injury or myopathy. The Veteran population has a significantly higher prevalence of muscle injury compared to the general population, which leads to long-term permanent disabilities. Given the national trends in the Veteran population regarding disability levels, it will be crucial to study the mechanism of skeletal muscle regeneration and maintenance during adult life. These studies will shed a new inside into the mechanism of muscle loss and develop new potential therapeutic targets, which the VA population will be the first to benefit from.